Glutamine Metabolism in the Human Newborn

at the top of each printed page and each continuationpage. Type density and size must conform to limits and specifications provided in the PHS 398 Instructions. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page .............................................................................................................................................. 1 Description,